Testing the therapeutic effectiveness of a topical agent to reduce diabetic wound pain and improve healing

PROJECT SUMMARY/ABSTRACT
The applicant is requesting five years of support from a NINR Ruth L. Kirschstein National Research Service
Award for Individual Predoctoral Fellows in Nursing Research (F31) to examine pain and wound healing in a
large animal model of diabetic ulcers. Painful and poorly-healing ulcers are a prevalent, yet understudied issue
among diabetic patients. In addition to risk for infection, there is also significant pain and decreased quality of
life associated with them. Use of a topical agent may improve healing and reduce pain; however, prior research
has shown limited benefit. In this study, we plan to use a clinically translational, large animal model with biological
similarities to humans, the diabetic miniature Yucatan swine. The effects of a novel topical agent on the speed
and quality of wound healing, as well as the behavioral response to wound pain stimuli, will be documented.
Following the experiment, tissue biospecimens and blood will be analyzed to examine transcriptomic changes
before and after wound induction and treatment—the results of which could provide mechanistic insight into the
effects of the topical agent on healing and pain behavior. The goal of this research is to test the hypothesis that
a novel topical agent, applied to wounds, will improve healing and improve pain behavior by altering biological
signaling pathways in the wound bed. I will test this hypothesis in two specific aims: (1) determine the efficacy of
a topical agent, applied to wounds, to improve wound healing and reduce pain behavior and (2) investigate
transcriptomic differences in wounds treated with the topical agent, as compared to placebo, prior to and
following injury and treatment. Wound diameter and granulation will be measured during the course of the healing
process. Pain will be determined using responses to mechanical and thermal nocifensive testing. Any withdrawal,
purposeful movement, grimacing, or vocalizations will be considered a valid sign of pain sensation. Since I am
interested in measurement of spontaneous pain behaviors, I will modify the piglet Pig Grimace Scale for adult
pigs. Transcriptomic changes in the wound will be evaluated using next-generation RNA sequencing methods.
This training will allow me to (1) develop skills in the areas of research design, analysis and interpretation using
a clinically translational large animal model; (2) learn about the fundamentals of pain physiology and genomics,
(3) successfully defend a dissertation; and (4) obtain a competitive post-doctoral fellowship with the long-term
goal to become a successful, independently-funded nurse scientist at a research-intensive university. The
proposal presented in this application incorporates the NINR mission of improving patient lives and its findings
may enhance scientific understanding of wound healing and pain reduction.

Public health relevance
PROJECT NARRATIVE Although pain and delayed healing in diabetic wounds are highly prevalent issues that need to be addressed, there have not been many systemic or topical agents that both improve healing and reduce pain. In this training project, I will use pigs, whose skin shares many characteristics with human skin, to test the effects of a topical agent compared with a placebo on wound healing and pain relief. The study's focus will enhance patient outcomes and improve quality of life.